An Enabling Technology for Human Cardiomyocyte Manufacturing

PROJECT SUMMARY
Human pluripotent stem cells (hPSCs) and their derived cardiomyocytes (hPSC-CMCs) are valuable for studying
and treating human diseases. However, their widespread use and further advancement to clinics are currently
limited by the difficulty of manufacturing these cells at large scales. The current cell culture methods have low
efficiency, are not scalable, and can only produce cells at small scales with high cost. For instance, making>10^10
hPSC-CMCs per batch is still very challenging. Additionally, there are significant variations in the yield and
properties of cells from different batches, labs, and companies, leading to inconsistent research and clinic results.
Further, the produced hPSC-CMCs have immature phenotypes that limit their use both in vivo and in vitro. The
overall goal of this project is to develop a novel cell culture technology to address this challenge. Toward this
goal, the team has developed a scalable, dissolvable, and cell-friendly 3D microbioreactor in the preliminary
studies. The microbioreactor provides cells a uniform, reproducible, well-controlled, and friendly
microenvironment, resulting in extremely high culture efficiency and consistency. The team has demonstrated
expanding hPSCs and differentiating hPSCs into cardiomyocytes in the microbioreactor. The viability, growth
rate, yield, and quality of cells in the microbioreactor offer large advances over current methods. The volumetric
yield is 250 times of current state-of-the-art. The new technology has all the needed features to address the
large-scale hPSCs and hPSC-CMCs manufacturing challenge. The proposed research will further develop and
vigorously validate the technology and the associated methods to make it robust and ready for hPSCs and hPSC-
CMCs manufacturing. Leveraging sound preliminary studies and a diverse team of experts, the specific aims are
to (1) validate the technology for culturing hPSCs from diverse backgrounds and (2) further develop and validate
the technology for preparing high-purity hPSC-CMCs. Completing this project, a scalable, clinically compatible,
and low-cost cell culture technology for culturing hPSCs and hPSC-CMCs will be available. The technology can
also be used for culturing other cells (such as platelets and red blood cells from hPSCs) related to National Heart,
Lung, and Blood Institute’s mission. The technology is enabling and will significantly advance medicine for heart
disease.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to develop a novel and cost-effective cell culture technology that enables culturing human pluripotent stem cells (hPSCs) and their derived cardiomyocytes (hPSC-CMCs) at various scales. These cells are needed in large numbers for cell therapy, tissue engineering, drug screening, and toxicity test. However, manufacturing them at large scales is still an unaddressed challenge.